Leica Cryostat for shared use at URI

The major goal of this project is to acquire a Leica CM3050 S Cryostat for a shared use at the
University of Rhode Island (URI). The majority of animal users at the URI demand a Cryostat to
fulfill the histological needs of diverse research projects. Three NIH-funded users have been
identified who are in critical needs of a Cryostat for successful conduct of their projects. Leica
CM3050 S Cryostat (configuration 2) is designed to process dedicate tissues and also has a
unique safety and user friendly design ideal for shared use. The cryostat will be integrated into
the Rhode Island IDeA Network of Biomedical Research Excellence (RI-INBRE) core facility to
increase its user access. Leica cryostat is expected to greatly enhance the biomedical research
capacities at the URI and also benefit local users from other Institutions. The long-term goal of
this project is to establish a histological core to meet the needs of local users.

Public health relevance
Leica Cryostat is expected to meet the histological needs of local animal users and significantly enhance the biomedical research capabilities at the University of Rhode Island. Leica Cryostat will also aid in the research and development of novel drugs and vaccines against human diseases.